Epigenetic Regulation of Lysosomal Ceramide Signaling and Function in Arterial Myocytes: Role of Kmt6 Gene

Project Summary
Arterial medial calcification (AMC) and arterial stiffening are a prevalent pathological process in different
pathological conditions or diseases such as hypertension, aging, atherosclerosis, diabetes and chronic kidney
disease. Enhanced exosome secretion by smooth muscle cells (SMCs) has been reported to be an essential
mechanism for calcifying nidus formation and extracellular matrix mineralization in the arterial wall to result in
AMC. Recent studies have also shown that lysosome function plays a critical role in controlling multivesicular
body (MVB) fate and enhancing exosome secretion and thereby in the development of arterial calcification.
However, it remains poorly understood how lysosome function is controlled to determine exosome secretion
and thereby lead to AMC. This proposal seeks to explore a novel epigenetic mechanism that regulates
lysosome trafficking and exosome secretion, which may contribute to the development of AMC. This
epigenetic regulation of lysosome function may be associated with the lysine methyltransferase Kmt6-
mediated repression of gene transcription of Smpd1, a lysosome enzyme that hydrolyzes sphingomyelin into
ceramide. Kmt6 is considered as a crucial epigenetic regulator that represses the target gene expression by
methylation of lysine residue in histone proteins. In preliminary studies, we demonstrated that SMC-specific
Kmt6 gene deletion exacerbated AMC and arterial stiffening, which were associated with increased Smpd1
expression and ceramide production, reduced lysosome TRPML1 channel activity, and lysosome trafficking
dysfunction. These observations led us to hypothesize that Kmt6 is an essential epigenetic regulatory enzyme
that controls lysosomal Smpd1-mediated sphingolipid metabolism and thereby regulates lysosome trafficking
or its fusion to MVBs and subsequent exosome secretion in SMCs. Kmt6 gene defect or functional deficiency
may disturb lysosome-mediated degradation of MVBs leading to increased exosome secretion, calcifying
nidus formation, osteogenic transition, and ultimately AMC in face of different pathological challenges. To test
this hypothesis, the following Specific Aims are proposed. Aim 1 will determine loss of Kmt6 contributes to
osteogenic transition and AMC in SMC-specific Kmt6 knockout mice with analysis of SMC phenotypes and
calcification. Aim 2 attempts to test whether Kmt6-mediated epigenetic regulation of Smpd1 critically controls
lysosome trafficking and exosome secretion by increasing TRPML1 channel activity and associated Ca2+
release using patch clamping of isolated lysosomes and lysosome-specific Ca2+ imaging. Aim 3 will explore
the molecular mechanisms how Smpd1 gene is epigenetically regulated by Kmt6 with a focus on its action on
histone and DNA methylation in cultured arterial SMCs. Our findings will for the first time define an epigenetic
mechanism controlling Smpd1 expression and activity via Kmt6 in SMCs and reveal a novel role of epigenetic
dysregulation of sphingolipid metabolism in the development of AMC and arterial stiffening. These findings
may also identify novel therapeutic targets for the treatment of AMC under different pathological conditions.

Public health relevance
Project Narrative: Smooth muscle cells secrete exosomes, which are very small particles containing various bioactive lipids, microRNAs or proteins and if increasing may contribute to calcium deposition in the artery wall leading to arterial hardening and increasing risk for cardiovascular disorders. This grant application for the first time explores a molecular mechanism regulating exosome release at the DNA level and determines whether the deficiency of this regulation causes arterial calcification and hardening. Our findings will help answer an important question how arterial hardening starts within cells at the very early stage of patients with cardiovascular risk factor such as hyperphosphatemia and will help develop new strategies for treatment and prevention of cardiovascular disorders.